DEVELOPMENT OF PCR TECHNIQUES FOR MYCOBACTERIAL DETECTION

Rapid detection of mycobacteria such as Mycobacterium tuberculosis and Mycobacterium avium intracellulare is critical for providing appropriate early treatment and determining the need for patient isolation. In smear- negative specimens, mycobacteria can presently only be detected by culture, which generally requires a minimum of about seven days and often much longer. An attempt will be made to use PCR methodology for the rapid detection of mycobacteria, first in culture media after allowing a very brief period for bacterial growth, and then hopefully directly in patient specimens. Presently we are working on the methodology for obtaining sterile extracts of DNA from mycobacteria.